Acquisition of Unix Computer Cluster for Molecular Dynamics Simulation Calculations

PROJECT SUMMARY
In response to NOT-GM-22-017, Notice of Special Interest: Administrative Supplements for
Equipment Purchases for Select NIGMS-Funded Awards, we request funds to upgrade our local Unix
compute cluster, which was purchased in 2012, with GPU nodes that are needed for the calculations
described on the parent grant. Our parent grant aims to understand the formation of non-enveloped
organelles and condensates. Many calculations of smaller size arise and are hampered by writing
supercomputing proposals. The current nodes are nearly impossible to maintain due to changes in
hardware compatibility. Our calculations focus on deciphering the thermodynamic manifold, enthalpic
versus entropic driving forces, underlying the solubility limit and consequent phase transition
associated with the formation of condensates.1 We also investigate the role of
compositional/sequence dependencies and protein disorder2 on the formation and stability of these
assemblies. Design of therapeutic targets that promote or inhibit formation of component proteins or
nucleic acids in biomolecular condensates requires a detailed understanding of the molecular forces
that drive their formation or dissolution. We will consider model mixtures relevant to cell signaling
consisting of pentapeptides GGXGG, GGpXGG, and GXGXG systems, where X is serine, threonine,
and tyrosine, to model the compositional dependency on condensate formation. We will also study
the mitochondrial Cox17 protein where the level of disorder is controlled by physiological conditions.3
This 60 aa protein is an ideal system to test our insights from the small pentapeptide model studies.

Public health relevance
PUBLIC HEALTH RELEVANCE Changes in protein disorder are important for many cellular functions and we use theoretical and computational methods to quantify the contributions of protein components to the formation of aggregates and biomolecular condensates. Future studies involve protein mixtures and the Cox17 protein which aggregates in Lewy-like bodies as found in neurological disorders. The fundamental mechanistic insights to be gained from these studies will allow an understanding of the difference between physiological and pathological nonenveloped organelles to guide plausible diagnostic and therapeutic solutions.